Complement and thrombosis in HIT

ABSTRACT
Heparin-induced thrombocytopenia (HIT) is a thrombotic disorder caused by ultra-large immune complexes
(ULICs) composed of IgG antibodies (Abs) to platelet factor 4 (PF4) and heparin (H). Even with prompt
recognition, discontinuation of heparin, and institution of alternative anticoagulants, thrombotic risk remains high
and persists for weeks. Studies from our last funding cycle suggest that therapy targeting complement may
improve outcomes. We showed that HIT ULICs potently activate the classical pathway of complement, elicit
complement-dependent binding of ICs to neutrophils (PMNs) and monocytes, and promote Fcγ receptor (FcγR)-
dependent PMN degranulation and monocyte tissue factor (TF) expression. Importantly, we saw striking
differences in complement-dependent responses to HIT ULICs formed in the presence and absence of heparin.
With heparin, HIT Abs bind to circulating PF4/H complexes forming soluble ULICs that bind to PMNs/monocytes
in a complement-dependent manner to promote leukocyte-driven cytokine release and monocyte TF expression.
Without heparin, HIT Abs bind to cell-surface GAGs on endothelial cells (ECs) and platelets, rather than white
cells, forming cell-bound ICs that drive complement-mediated platelet adhesion and EC procoagulant activity.
Based on these observations, we will test the hypothesis that complement responses to HIT ULICs are impacted
by heparin itself and involve distinct cellular targets, activation pathways and effector mechanisms though the
following specific aims: 1) Cell injury by soluble HIT ULICs requires complement and Fcγ receptors. We
show the importance of the proximal complement pathway (C1/C3) for binding of soluble HIT ULICs to PMNs
and monocytes via complement receptors (CRs). We hypothesize that binding of soluble HIT ULICs to CR1/CR3
initiates cell signaling and cytoskeletal reorganization, FcγR clustering, membrane scramblase and monocyte TF
expression. 2) Cell-bound HIT ICs promote complement-dependent platelet adhesion and direct
endothelial injury. We show terminal complement pathway mediated platelet adhesion to injured EC and
upregulation of EC procoagulant activity by cell-bound ICs. We hypothesize that cell-bound HIT Abs initiate
sublytic C5aR-mediated membrane injury leading to further upregulation of C5aRs, release of high molecular
weight von Willebrand Factor multimers, and C5aR-dependent TF expression. 3) Complement activation as a
biomarker for pathogenic HIT antibodies. Our studies show a strong correlation of complement activation with
platelet-activating effects of HIT ULICs. We will test the hypothesis that complement activation identifies a subset
of pathogenic HIT Abs by characterizing the biologic properties of HIT IgG Abs that do/do not activate
complement and form soluble and cell-bound ULICs, develop complement activation as a biomarker assay, and
examine complement’s role in the therapeutic efficacy of intravenous immunoglobulin. Together, these proposed
studies of complement in HIT will advance our understanding of its underlying pathology, should improve
diagnostic testing and position complement inhibitors as adjunctive therapy for this prothrombotic disorder.

Public health relevance
PROJECT NARRATIVE Heparin causes a life-threatening allergy called heparin-induced thrombocytopenia (HIT) that is challenging to diagnose and treat. Our laboratory has identified contributions of an ancient immune pathway called complement promotes clotting problems in HIT. This application seeks to understand how complement promotes clotting in HIT and may open doors for using anti-complement therapy for treatment of HIT.